HUMAN C1 INHIBITOR IN HEREDITARY AND ACQUIRED ANGIOEDEMA

Open-label study of C1 INH-IMMUNO in the treatment of Hereditary Angioedema (HAE). HAE is a condition in which acute, recurrent episodes of well circumscribed, nonpitting, subepithelial edema primarily involving the extremities, face, abdomen, and larynx. HAE is characterized by a marked decrease in functional C1 inhibitor. This study attempts to control the symptoms of HAE by administering C1 inhibitor. The C1 inhibitor is effective therapy for the treatment of attacks of HAE with no adverse reactions.